Dysregulation of developing neural circuits during epileptogenesis

New neurons are born throughout life: their generation, integration and function are tightly
regulated. Impairment of this process is associated with brain circuit dysfunction and the
development of epileptiform activity and sensory hypersensitivity, associated with
neurodevelopmental disorders. In several models of epileptogenesis, prior and repeated seizure
activity (e.g. from traumatic brain injury) results in increased seizure susceptibility and
eventually epilepsy. Neurogenesis is known to be disrupted following repeated seizure activity,
which can alter cell proliferation, survival, differentiation and functional maturation of new
neurons as they incorporate into existing neural circuits. Since altered neurogenesis has been
shown to be a causative factor in both spreading depression and seizure generation, both
pathophysiological hallmarks of epilepsy, it is important to understand whether abnormal circuit
activity and perturbed neurogenesis cause newborn neurons to improperly integrate and
function within existing brain circuits, disturbing activity and leading to epilepsy.
This proposal tests the hypothesis that seizure activity and network hyperexcitability perturb
development and function of new neurons, resulting in highly excitable neurons that potentiate
network hyperexcitability and lead to epilepsy and sensory hypersensitivity.
We will a reduced preparation, the Xenopus laevis tadpole tectum—an established model for
studying generation of new neurons and the biological basis for epilepsy. It is a highly recurrent
structure with ongoing integration of new neurons, and thus ideally placed for understanding
the fundamental biological underpinnings of developmental epilepsy. We will use genetic
methods to tag later-born neurons and follow them in vivo as they integrate into existing brain
circuits following developmental seizure exposure. We will measure the structure and
physiology of these neurons as they mature. We will then test whether we can manipulate the
electrical activity of these miswired neurons and test whether we can ameliorate seizure
activity. Finally, we will examine genes that are expressed incorrectly in later born neurons
following a seizure to test whether these genetic pathways can be responsible for the abnormal
development of these neurons and miswiring of the brain following a seizure. Improving our
understanding of how exposure to prior seizures aﬀects the maturation of neural circuits, and
how this in turn leads to epilepsy will not only help illustrate the basic biology underlying
epileptogenesis, but will result in potential therapeutic targets that could prevent formation of
epilepsy following a series of seizures, such as those experienced after brain injury.

Public health relevance
Narrative (Public Health Relevance) A major focus of epilepsy research is to understand how brain cells and circuits become permanently overexcited, such that they lead to the development of epilepsy and seizure generation. This proposal focuses on the role of dividing brain cells that are born later in life, and which their development can be altered by the experience of early seizures and thus become mis-wired into the existing brain, facilitating the development of epilepsy and leading to sensory processing disorders associated with several neurodevelopmental disorders. Understanding this process, at the basic science level, could one day lead to treatments to prevent the development of epilepsy after a seizure, such as those occurring after traumatic brain injury.